Bioengineering of Enucleated Cell Therapeutics for Treating Inflammatory Diseases

New therapeutics often fail to reach the clinic due to poor efficacy and severe adverse toxicity, primarily arising from
inadequate drug delivery mechanisms. This inefficiency costs the pharmaceutical industry billions annually, underscoring
the urgent need for targeted drug delivery systems that can accurately target diseased tissues while minimizing off-target
toxicity. In recent years, innovative delivery strategies—such as nanoparticles, exosomes, whole cells, and red blood cells—
have been developed to deliver therapeutic agents. However, despite these advancements, no fully developed and clinically
viable intravenous drug delivery system currently exists. Thus, the development of precise delivery mechanisms to diseased
tissues offers a significant opportunity to treat a broad spectrum of conditions safely. Our laboratory has pioneered a novel
therapeutic delivery system, "Cargocytes," designed to transport therapeutic cargo directly to inflamed and damaged tissues
with precision. These transporters are derived from mesenchymal stem cells (MSCs) genetically engineered with
chemoattractant receptors (CCR2 and CXCR4) and the endothelial adhesion molecule (PSGL-1). This GPS-like guidance
system allows Cargocytes to respond to P- and E-selectins on inflamed endothelial cells and chemoattractants (CCL2 and
CXCL12) secreted by diseased tissues. The MSCs are then enucleated via gentle density gradient centrifugation and
transfected with mRNAs encoding the therapeutic payload before intravenous administration. Our work shows that
enucleation bestows the Cargocyte with unique functional and biophysical properties while providing significant safety
advantages for therapeutic delivery.
This application aims to:
Aim 1: Optimize the in vitro production, cryopreservation, and biobanking of Cargocytes for subsequent studies.
Aim 2: Conduct comprehensive immunogenicity and organ toxicity tests in vitro and in vivo using established
immunocompetent mouse models.
Aim 3: Evaluate the ability of optimized Cargocytes carrying an IL-10 payload to treat inflammatory pancreatitis
effectively and safely in a preclinical mouse model of caerulein-induced chronic pancreatitis.
Through these objectives, we aim to establish Cargocytes as a groundbreaking therapeutic delivery platform capable of
addressing the unmet need for precise, targeted drug delivery in clinical applications.

Public health relevance
Many drugs fail to reach the clinic due to improper delivery leading to unwanted adverse events (toxicity). Work in this application will engineer a novel precision drug delivery system called Cargocytes that limits drug toxicity and improves clinical outcomes for a wide range of therapeutics.